Administrative supplement to align with FAIR and TRUST principles

This project seeks to strengthen the compliance of the CHILDES (Child Language Data Exchange System) Project with the FAIR and TRUST standards. CHILDES provides data in the form of transcripts and linked media for the study of child language development. This supplement to the CHILDES grant will allow us to improve the findability, accessibility, interoperability, and reusability of the database. These improvements will transfer without further work to 13 other NIH databases for the study of normal and disordered spoken language.

Public health relevance
This project seeks to strengthen the compliance of the CHILDES (Child Language Data Exchange System) Project with the FAIR and TRUST standards. CHILDES provides data in the form of transcripts and linked media for the study of child language development. This supplement to the CHILDES grant will allow us to improve the findability, accessibility, interoperability, and reusability of the database. This will be done through improvement of metadata, versioning, data lineage, usage metrics, publication metrics, user surveys, format interoperability, and sustainability. These improvements will transfer without further work to 13 other NIH databases for the study of normal and disordered spoken language.